Rare Bronchiectatic Diseases Consortium

PROJECT 2 ABSTRACT
Rare genetic diseases are associated with bronchiectasis (BE) as a severe pulmonary disease manifestation.
People with rare genetic diseases with BE experience increased sputum production, loss of lung function, an
increased frequency of respiratory exacerbations, and life limitation. There is a great need for novel therapies
for people with rare genetic diseases and BE. Project 2 will study four rare diseases with diverse genetic
mutations, including: 1) primary ciliary dyskinesia (PCD); 2) alpha-1 antitrypsin deficiency (α1AT); 3) humoral-
immune deficiency (HID); and 4) STAT3-hyper IgE syndrome (STAT3-HIES). Each disease exhibits unique and
variable components of dysfunction in elements that mediate airways host defense, including epithelial defects
(PCD), humoral defects (HID, α1AT), and cellular immune defects (STAT3-HIES). Project 2 proposes to use a
new paradigm describing key initiating factors that fuel a vicious vortex cycle (Vicious Vortex 2.0) to identify
biomarkers and treatable traits common to all four rare genetic diseases juxtaposed to a goal to identify
biomarkers/treatable traits unique to each rare disease. The technologies employed to accomplish these goals
combine: 1) high-content RNA/protein spatial technologies applied to a unique set of excised lungs from each of
the four genetic diseases; with 2) studies of airway epithelia obtained at bronchoscopy from Project 1 for in vitro
investigations of disease-common or -specific epithelial responses to mimics of aspiration (pH, bile acids),
viruses (RSV), and normal vs disease-specific oral microbiomes. Accordingly, Project 2 proposes three specific
aims:
Specific Aim 1: Test the hypothesis that each rare disease has a common core of Vicious Vortex 2.0-
associated features, but with disease-specific modifications/additions, in excised lungs. Spatial RNA and
protein technologies will interrogate lungs excised from subjects with PCD, α1AT, HID, and STAT3-HIES.
Specific Aim 2: Test the hypothesis that there are rare disease-common and disease-specific responses
to mimics of aspiration and viral infection. This aim will utilize cells obtained from the four rare diseases at
bronchoscopy (Project 1) to identify common disease-specific airway epithelial responses to triggers of
obstruction/hypoxia, including mimics of aspiration and viral infection.
Specific Aim 3: Test the hypothesis that there will be rare disease commonalities and differences in
airway epithelial responses to “normal” oral microbiome challenges and disease-specific differences in
oral microbiome that are disease pathogenesis-relevant. Like SA2, SA3 will utilize bronchoscopy-derived
airway cells and disease-specific oral microbiomes.
Project 2’s ultimate deliverables are the identification of clinical trial vetted/novel biomarkers and novel treatable
traits common to the BE experienced by patients with these four rare diseases and unique biomarkers/treatable
traits tailored to unique rare disease patient populations.